Vascular Regeneration with Direct Reprogramming and Engineering Strategies

Project Summary
Ischemic cardiovascular diseases are the leading cause of morbidity and mortality. Underlying
pathophysiology of these diseases is associated with loss or dysfunction of blood vessels and/or impaired new
vessel formation (neovascularization). While cell therapy has emerged as a promising option to form blood
vessels, the effects of adult stem cells are uncertain and embryonic or induced pluripotent stem cells
(ESCs/iPSCs) are potentially tumorigenic. To avoid these problems, a new approach has been developed using
lineage- or cell-type specific transcription factors (TFs) for direct conversion or reprogramming of somatic cells
into other lineage cells. We have attempted this direct reprogramming toward endothelial cells (ECs) using
combinations of seven TFs and found for the first time that ETV2, alone, is sufficient to convert human fibroblasts
into ECs. However, since we used a lentiviral vector, these reprogrammed ECs (rECs) have limited clinical
applicability.
The direct reprogramming approach allows two therapeutic strategies: cell-based therapy or direct in vivo
reprogramming. For clinical application, both approaches require a safer delivery vector to minimize the
possibility of genomic integration. Thus, we developed an adenoviral-ETV2 (Ad-ETV2) vector and generated
rECs (Adeno-rECs). Another important barrier for cell therapy is short-term survival of the transplanted cells. To
overcome this problem, we have been investigating bioengineered cell therapy.
In this study, first, we will generate an optimal construct combining these Adeno-rECs with novel
biomaterials. We have developed a novel biodegradable hybrid copolymer consisting of gelatin and poly glycerol
sebacate (PGS), which was further made into a microbead form with alginate. We refer to this co-polymer as
AlGPM. This hybrid polymer is biodegradable and elicits minimal inflammatory response. Furthermore, its
microbead form promotes wide distribution of encapsulated cells after injection. The composition of AlGPM will
be optimized to promote cell survival and maximize function of rECs. We will then determine the
neovascularization and therapeutic effects of the selected AlGPM microbeads encapsulating rECs using
ischemic animal models. Second, we will determine whether local injection of viral particles of ETV2 into animal
models can directly reprogram somatic cells into endothelial cells and promote vascular regeneration and tissue
repair in vivo. Moreover, by using various transgenic mice, we will genetically track the fate of somatic cells
toward ECs in vivo. Together, the goal of this project is to develop clinically applicable vascular regenerative
therapy using direct reprogramming approaches and bioengineering technologies.

Public health relevance
Project Narrative Ischemic cardiovascular diseases are the leading cause of morbidity and mortality in the USA; however, clinical therapies aiming to grow blood vessels in the body are currently lacking. Recently, we developed innovative technologies for directly reprogramming somatic cells toward endothelial cells (rECs) using the ETV2 gene, bypassing a stem cell stage. In this proposal, we will develop a clinically compatible ETV2 vector and rECs engineered with a novel biomaterial, and determine the therapeutic effects of direct delivery of ETV2 gene and engineered rECs on ischemic animal models.